Using Natural Mouse Movement to Establish a Developmental "Biomarker" for Corticospinal Damage

The corticospinal tract (CST) is a critical circuit underlying skilled voluntary movements. Damage to this circuit
during development can cause permanent, long-term movement disability in humans. Recognizing and treating
such developmental CST damage is challenging, largely because immediately after the lesion, there are limited
or almost no functional deficits. However, early recognition and intervention with the appropriate treatment
measures is key to reducing long-term disability. The use of preclinical mouse models, which have otherwise
proven to be highly useful in functional investigations of nervous system development, has been limited in this
regard. Since the CST is known to control skilled movements, established behavioral tests in mice that
investigate CST function require training mice in skilled tasks. This precludes their application in neonatal mice.
Further, mouse models used to investigate developmental CST damage, e.g. neonatal hypoxia or spinal injuries,
do not only damage the CST; rather they disrupt multiple neural pathways. It therefore remains completely
unknown whether the CST contributes only to skilled movements in adult mice, or whether it also contributes to
the development of natural, innate motor ability during development, beginning in neonatal mice. This latter
possibility would suggest that there are early, albeit subtle, behavioral correlates of developmental CST injury in
mice. We recently developed a new microsurgical approach to specifically disrupt the developing CST in
neonatal mice. In addition, we have also established the use of Motion Sequencing (MoSeq), a new machine
learning and artificial intelligence platform, to longitudinally investigate the development of natural movements
in neonatal mice. Our preliminary results using MoSeq suggest that developmental damage to the CST results
in specific changes to movement structures in mice, as early as P12; these extend into maturity at P35. Further,
analysis of these P35 mice using conventional metrics of locomotion such as the Catwalk, did not identify any
deficits, highlighting the sensitivity of MoSeq in identifying changes in mouse movements. This proposal
investigates the hypothesis that the CST controls development of natural mouse movements, and not only skilled
movements at maturity. We will use MoSeq to analyze Fezf2 knock out (Fezf2 KO) mice in which the CST is
never established during development (Aim1), as well as mice that undergo microsurgical lesions to disrupt
spinal connectivity of the CST at distinct developmental times (Aim2). Together, our work will identify novel
functional readouts of developmental damage to the CST using natural mouse movements. This new unbiased
quantitative approach toward investigating the earliest behavioral signs of corticospinal dysfunction in mice which
will have eventual application in investigations of descending circuits of motor control, as well as multiple
preclinical models of developmental damage such as neonatal hypoxia or spinal injuries.

Public health relevance
The proposed research is relevant to public health because developmental damage to the corticospinal tract in cerebral palsy and after neonatal spinal injuries represents a significant burden to their family as well as a major cost burden to the health care system. For successful diagnosis and treatments, a critical need is to have better approaches that can accurately predict long-term movement disability in babies born with brain damage, a presently unattained goal, in part because of a lack of good mouse models to investigate this problem. Our proposed research will identify early biomarkers to predict long-term disability in mouse models of corticospinal dysfunction that can eventually be applied toward diagnosing and predicting disability, as well as evaluating efficacy of treatments in humans with developmental brain damage.